Prenatal Social Connection and Disruption During the COVID-19 Pandemic: Effects on Maternal and Infant Health

PROJECT ABSTRACT
The proposed diversity supplement requests funding for Gabriel León, a first-
generation college graduate of Latino heritage (Mexican American) and Pell Grant recipient,
who is a graduate student working on the NICHD-funded project, 5R01HD104801, “Prenatal
Social Connection and Disruption During the COVID-19 Pandemic: Effects on Maternal and
Infant Health.” The PI of that project, Dr. Darby Saxbe, is Mr. León's primary graduate
research mentor and will work closely with him as he pursues his research interests in
interpersonal emotion synchrony between parents and their infants. His interests are directly
related to the primary aims of the funded R01 grant, which assesses how social connection
benefits maternal and infant health in the wake of the COVID-19 pandemic.

Public health relevance
PROJECT NARRATIVE The proposed diversity supplement requests funding for Gabriel León, a first-generation college graduate of Latino (Mexican American) heritage and a Pell Grant recipient, who is a graduate student working on the NICHD-funded project, 5R01HD104801, “Prenatal Social Connection and Disruption During the COVID-19 Pandemic: Effects on Maternal and Infant Health.” Mr. León's research interests focus on interpersonal emotion synchrony between parents and their infants. These interests are directly related to the primary aims of the funded R01 grant, which assesses how social connection benefits maternal and infant health in the wake of the COVID-19 pandemic.